Clinical Validation Center for Lung Cancer Early Detection

Abstract
The lung cancer early detection CVC has two main goals: Specific Aim 1 is to develop a blood-
based biomarker panel for personalized risk assessment, modeled for its cost effectiveness. To
this effect, substantial validation work in phase 3 studies has been done using retrospective
longitudinal cohorts to test the performance of a four-marker protein panel (4MP) as a means to
determine lung cancer risk and need for CT screening. The goal moving forward is to test the
4MP alone and in combinations with other types of markers in the screening setting, using lung
cancer screening cohorts available to the CVC. The resulting marker panel, in combination with
subject characteristics, would identify subjects who are currently not eligible based on USPSTF
criteria that would benefit from CT screening based on their risk, ultimately leading to a utility trial
for which a concept has been presented at a recent EDRN scientific meeting. The utility trial
concept also includes as an objective to test the value of biomarkers in informing subjects who
are currently eligible but not decided to undergo CT screening, about their risk through a decision
sharing process. Specific Aim 2 will test the use of biomarkers and AI for interpretation of CT
images and to personalize the screening frequency and duration. Sub Aim 1 is intended to validate
the macrovasculature surrounding a nodule (vessel number) previously developed as a
biomarker, in an independent screening cohort. Sub Aim 2 is intended to develop a validated
integrative computational model for improved early lung cancer detection that includes blood-
based biomarkers, CT features such as emphysema, presence or absence of a nodule, small
airways and subject characteristics for interpretation of CT images and to determine screening
frequency. The model will be subjected to a cost effectiveness analysis compared to current lung
cancer screening guidelines.
The CVC represents a multi-institution, multi-investigator effort with expertise in cancer
biomarkers and statistics; pulmonology and lung cancer; epidemiology; radiomics, bioinformatics
and artificial intelligence; and clinical trial design, simulation modeling and cost-effectiveness
analysis. The CVC brings in substantial accomplishments in biomarker discovery and validation
related to lung cancer screening and in CT image analysis. In pursuit of its aims, the CVC has
access to samples from a multitude of cohorts for validation studies.

Public health relevance
A team of investigators with a track record of collaboration and relevant expertise is proposing a Clinical Validation Center with two specific aims that are intended to validate blood based biomarkers and artificial intelligence based analysis of CT images as means to improve lung cancer screening. CVC investigators bring in substantial accomplishments relevant to the goals of the CVC as well as substantial resources in the form of several lung cancer screening cohorts with imaging data and blood samples to contribute to the success of the CVC in achieving its goals.